Administration and Biostatistics Core

The administrative and biostatistical core will function as a resource for the entire Program. The administrative core is responsible for the financial management of the Program, coordination of training, production and maintenance of all PPG correspondence, communication and operational support. Core A will support the regular meetings of the PPG investigators, coordinating schedules, meeting space and videoconferencing with distant sites (UCSF and University of Chicago). The Core provides for internal and external advisers, who give critical feedback but do not have a governance role in the Program. Core A will support communications with and coordinate an annual meeting of an internal advisory committee with Program investigators. Core A will arrange individual visits of 3 external advisers per year to provide consultation to the Program and present in the Developmental Biology and Neuroscience Seminar Series at Cornell or UCSF. The core will coordinate the distribution of reports to the external advisers and critiques to the Executive Committee of Project Pis as well as arrange an annual end-of-year discussion among external advisers and Pis via phone conference. The Biostatistics subcore is housed within Core A and maintains a centralized Access" database that is shared across all projects. This database is designed to standardize data classification and archiving so that investigators from all Projects and Cores can access developmental, anatomical, neurophysiological and behavioral data on all genetic models. The administrative Core also coordinates statistical support for all projects through consultants from the Department of Public Health of the Medical College of Cornell (see section on the Biostatistical subcore). Because their primary faculty appointments are at Cornell, Core A will administer Dr. Polan's and Dr. Suh's salaries that are related to their research efforts on Project 4 (Moore PI, Columbia University). Thus, Core A serves every project and core in the Program.